Community Outreach Core

ABSTRACT – COMMUNITY OUTREACH CORE
The goal of the Community Outreach Core (COC) is to continue supporting the Florida-California Cancer
Research, Education, and Engagement Health Equity (CaRE2) Center by sharing scientific data and results
from ongoing projects with throughout our communities, promoting clinical research education, and training
community members to be advocates and community influencers on cancer. Our Community Outreach Core
(COC) team has over 20 years of experience working in bicoastal community engagement research, with
diverse populations including but not limited to, Black, African American, (B/AA) and Hispanic/Latinox (H/L)
individuals of various country origins and of low socioeconomic status. We will continue supporting Center
investigators conducting prostate, pancreatic, and now, lung cancer research. Building on COC’s prior work,
four (4) aims to accomplish are to 1) Create and implement a Community Advocacy Academy designed to
train, support, and measure the impact of 600 community advocates in sharing information about cancer,
cancer research, and the CaRE2 Center and its projects 2) Develop and deliver to 5,000 community members
evidence-based multimedia educational materials, maximizing the use of technology and media, tailored to B/
AA and H/L audiences, focusing on pancreatic and lung cancer information, cancer research and clinical trials
participation, and biospecimens donation for cancer research. 3) Partner with CaRE2 investigators to host
educational activities to inform and educate B/AA and H/L diverse populations and other key stakeholders
about cancer research advances and CaRE2 center discoveries. 4) Partner with the CaRE2 Planning and
Evaluation Core to evaluate the effects of the COC program and activities.